Outreach, Recruitment, and Engagement (ORE) Core

REVISED ABSTRACT:

Outreach, Recruitment, and Engagement Core: Project Summary –2P30AG066530-06 (5769)
The overall objective of the Outreach, Recruitment and Engagement Core (ORE Core) is to serve as the primary bilingual and bicultural resource and liaison between the USC ADRC, our study participants, their caregivers/partners, and the larger community, i.e., the general public, people living with dementia and caregivers, professional care providers, and the lay community in Los Angeles County. The ORE Core facilitates bidirectional communication through our signature outreach and engagement activities, USC GeneScreen registry, and recruitment from the LA County Department of Health Services (DHS). We will: Aim 1: Engage in Participant Recruitment & Develop a Research Registry: The ORE Core will maintain and further develop USC GeneScreen, a registry of persons in the LA County area interested in participating in studies and enriched for APOE ε4 carriers. We will augment Latino participation (English, Spanish, low socioeconomic status) in the registry given the higher prevalence and disease burden in this population and our catchment area composition. During the next 5 -years, our goal is to genotype and register a diverse pool of 1500 participants who are “study-ready” to enroll in AD/ADRD research. Aim 2: Enhance Recruitment from the LA County Department of Health Services (DHS) at the Rancho Los Amigos National Rehabilitation Center (RLANRC). Our ADRC is affiliated with the California Alzheimer’s Disease Center (CADC) based at RLANRC, an integral part of the DHS safety-net community health system whose goals are to ensure quality health care for all regardless of socioeconomic status. Through work there, we will identify and invite RLANRC patients with MCI or mild dementia to participate in ADRC research studies. Aim 3: Continue to Engage in Bidirectional Education, Information and Resource Sharing: In collaboration with our extensive network of community partners, we will continue to serve as a community resource in targeted engagement and educational outreach to the public-at-large, healthcare and human service providers, potential study participants, and current participants. We will communicate the latest ADRC- and AD/ADRD research findings and timely information on brain health, aging and wellness.